Environmental and Sanitation Improvements with mHealth

PROJECT SUMMARY
More than half of the world’s population is urban. While economic opportunities often drive migration to urban
settings, the benefits of increased economic opportunity, environmental and health infrastructure in cities is not
adequate or equitable. While urban areas may have greater sanitation coverage, those in densely populated,
slum communities experience disparities in distribution, quality, and continuity of these water and sanitation
services. In conjunction with government investment, the issues of collective action, stakeholder engagement,
inclusive and sustainable practices remain critical to impactful urban sanitation solutions. Addressing the major
barriers to effective urban sanitation interventions such as building mechanisms for communication between the
residents of the vulnerable communities and the service providers at scale has the potential to make a
tremendous impact on health and well-being. Mobile health technology has tremendous potential to gather data
directly from the underserved populations in need of sustainable water and sanitation solutions and enhance the
inclusion of vulnerable populations in the participatory construction of these solutions.
The primary purpose of this proposal is to develop and evaluate a mobile health technology program to enhance
urban sanitation interventions in densely populated and marginalized urban communities to increase connections
and engagement with sanitation interventions, and result in reduced environmental contamination. Through
formative research, a pilot feasibility investigation, and a validation study, we will determine the ability of the
mHealth program to enhance urban sanitation interventions.

Public health relevance
PROJECT NARRATIVE The economic, environmental and health infrastructure in cities is not equally distributed nor sufficient to serve this growing urban population. Poor urban sanitation is responsible for disproportionate health impacts especially in underserved communities. mHealth has tremendous potential to engage and include underserved populations to increase access to inclusive sanitation solutions resulting in positive impacts on health and well-being.